The role of OPC-microglia interactions in TDP-43-related neurodegeneration

PROJECT SUMMARY
TAR DNA-binding protein-43 (TDP-43) aggregation is seen in neurodegenerative diseases such as amyotrophic
lateral sclerosis (ALS) and frontotemporal dementia (FTD). These diseases present a significant burden to
patients and caregivers, with little promising intervention to date. Interactions between oligodendrocyte precursor
cells (OPCs) and microglia are increasingly recognized to play a role in disease states. OPCs are able to
differentiate into oligodendrocytes, the primary myelin-forming cells of the central nervous system (CNS).
However, they are also involved in modulating activity of immune cells such as microglia, the principal immune
cells of the CNS. In models of neuroinflammation and neurodegeneration, OPCs play a neuroprotective role in
attenuating detrimental microglial proliferation. Understanding the mechanistic details of this OPC-mediated
neuroprotection has therapeutic implications. The objective of the proposed research is to determine the
mechanism underlying OPC-microglia interactions in TDP-43-related neurodegeneration and outline the
functional significance in terms of disease outcome. Our preliminary data in the rNLS8 mouse model of inducible
TDP-43 expression suggests that OPC-microglia interactions significantly increase during disease. Performing
predictive ligand-receptor analysis of transcriptomic data from human ALS patients highlights microglial secreted
phosphoprotein 1 (SPP1) signaling to OPC integrin receptors as a likely mechanism. We hypothesize that
increased OPC-microglia interactions occur through enhanced SPP1 signaling during TDP-43-related
neurodegeneration and serve a protective role by reducing microglial numbers and neuroinflammation.
To accomplish our objectives, we will use transgenic and viral mouse models of TDP-43-related
neurodegeneration. We will first address whether SPP1 signaling to OPC integrin receptors mediates this
interaction through immunohistochemical (IHC) staining and use of an SPP1 genetic knockout mouse model. To
investigate real-time dynamics and ultrastructure of this interaction, we will perform in vivo two-photon imaging
and serial block-face scanning electron microscopy. We next address the effect of OPC-microglia interactions
on disease progression through a pharmacogenetic OPC ablation mouse model. Following ablation, we will
measure readouts of neuroinflammation, neuropathology, and motor behavior function. Finally, we will confirm
the translational relevance of our findings by performing IHC staining to assess OPC-microglia interactions in
human ALS and FTD tissue. Successfully completing these aims will unveil a critical regulatory axis of
neuroinflammation in TDP-43-related neurodegeneration, providing a foundation for targeted therapeutic
interventions.

Public health relevance
PROJECT NARRATIVE Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are debilitating diseases with little promising therapeutic intervention. The proposed project will investigate an important regulatory axis of neuroinflammation that has direct outcomes on disease progression while outlining a novel function of oligodendrocyte precursor cells that has not been documented in the field. Accomplishing our objectives will further our mechanistic understanding of these diseases in hopes of opening novel avenues for disease- modifying therapies.